Computational Development of Novel Dyslipidemia Therapeutic Candidates to Disrupt ApoC-III Conformation

Project Abstract
Cardiovascular Disease (CVD) is a significant threat in the United States and developing countries
across the globe. Widely associated with elevated low density lipoprotein cholesterol (LDL-c),
therapeutic interventions are primarily focused on reduction of LDL-c plasma levels. Despite the
ability to therapeutically reach these target levels, many patients maintain high cardiovascular risk
profiles. A causal contributor to this therapeutic paradox is the development of triglyceride-rich
lipoprotein (TRL) particles, highly atherogenic remnant particles that are the result of impaired
lipase catabolism. Exhibiting resistance to current FDA approved LDL-c lowering medications,
these particles maintain significant cardiovascular risk despite the over lowering of LDL-c. It has
been determined that high apolipoprotein C-III (ApoC-III) is a hallmark of TRL particles. The
sinister nature of ApoC-III is well established as it possesses key functions that include, but are
not limited to; inhibition of Lipoprotein Lipase (LPL), impairment of HDL cholesterol efflux and
retardation of lipoprotein particle hepatic uptake. As a potential solution, iMBP is developing new
therapeutic compounds that target ApoC-III. Our current research efforts have computationally
identified the potential to induce a conformational distortion in the ApoC-III target upon binding.
Due to a highly flexible hinge region in the molecule that is necessary for ApoC-III to stabilize on
lipoprotein particles, the induction of a conformational change could provide a unique therapeutic
mode of action in action for reducing TRL levels. This proof-of-concept work is to computationally
reengineer a current proprietary therapeutic candidate to augmented ApoC-III distortion
capabilities. An expression library will then be expressed and top candidates will be functionally
tested for binding. Split into 2 Specific Aims, the final evaluation of feasibility testing will determine
the degree of distortion that is achieved as a consequence of binding. The milestone for this final
Aim is the identification of a molecule that binds ApoC-III and creates a measurable change in its
conformation exhibited as an increase in the protein’s end to end distance. The satisfaction of
this milestone would lead to a SBIR Phase 2 plan that would further evaluate the influence that
an artificially induced ApoC-III conformational distortion could play in destabilizing its lipoprotein
particle binding characteristics and assist in plasma clearance that would culminate in pre-clinical
testing.

Public health relevance
Project Narrative We are developing an innovative cardiovascular disease therapeutic approach based on the hypothesis that the structure of Apolipoprotein C-III (ApoC-III) can be distorted by binding an engineered antibody derived binder across the central hinge region. This conformational elongation may have significant influence on the ApoC-III lipoprotein binding and aid in clearance from the circulation.